DIETARY INTAKE AND THEOPHYLLINE METABOLISM IN THE PRETERM INFANT

This project studies the effects of gestational age and of dietary regimen (TPN vs full feed) on the kinetics of theophylline and its metabolites.